BIOLOGICAL CORRELATES OF PERSONALITY DISORDER

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Results of recent research suggest that genetic and biologic factors may greatly influence the development of personality. The objectives of these studies are to characterize the various factors which relate to familial (genetic), psychophysiological, and biochemical influences on personality.